Environmental Contaminants and Reproductive Health of Akwesasne Mohawk Women

The project led by Drs. Schell and Carpenter, entitled "Environmental contaminants and reproductive health of Akwesasne Mohawk women" builds on a collaborative relationship between the Akwesasne Mohawk Nation and the University at Albany reaching back some 20 years, while also representing an expansion of the Center's focus to the region beyond Albany and Amsterdam. The study's objective is to determine the effect of exposure to PCBs, other persistent organic pollutants and lead on characteristics of the menstrual cycle among Mohawk women who are between 20 and 35 years of age and living in Akwesasne, which is adjacent to a federal and two state Superfund sites. The study will enroll 180 women who will be followed through one menstrual cycle with collection of blood, urine and daily saliva samples to investigate the relationship of PCB congeners and other toxicants to gonadal function, pituitary function and other characteristics of the menstrual cycle measured through diaries and questionnaires. This study has several innovative methodological features: the simultaneous consideration of multiple toxicants with endocrine disrupting properties, the congener specific analysis of PCBs for testing structure-function relationships with regard to reproductive effects, the consideration of these effects within the context of other common influences on reproductive parameters, and the application of statistical techniques and growth curve analyses that take full advantage of the density of data obtained throughout the cycle. The project is equally notable for its meaning and salience to the community. Activities that express and reaffirm Mohawk identity and culture may increase exposure to local contaminants such as PCBs, particularly through diet. The findings of this study will have great significance not only for the promotion of good reproductive health (critical to the survival of the nation as a culture and a people) but also for understanding the risk possibly related to activities that have been traditionally associated with Mohawk ways of life.